Therapeutic Editing to Lower PrP in Prion Disease

PROJECT SUMMARY
The overarching goal of the parent grant is to file an Investigational New Drug (IND) application
with FDA to enable a first in human trial of PRNP-AAV-CHARM, a PrP-lowering epigenetic editor
therapeutic, in prion disease. The goal of this administrative supplement is to provide funding to
produce clinical-grade drug product at a scale that will support our first-in-human clinical trial in
N=10 prion disease patients. This clinical study will very likely be the first time either CHARM or
the BI-hTfRv2 viral vector are tested in humans. If this human proof-of-concept is successful,
both technologies stand to be of use against a wide range of other CNS diseases.

Public health relevance
PROJECT NARRATIVE Prion disease is a rapid neurodegenerative disease with no current standard of care. We have developed an epigenetic editor therapeutic for prion disease that efficiently reduces the expression of the causative protein, PrP, in animals. Successful completion of this research project would result in submission of an Investigational New Drug (IND) application to the FDA.